Chemistry-Biology Interface Predoctoral Training Program

Project Summary
This proposal requests funds to support predoctoral trainees as part of the Chemical Biology Interface Training
Program (CBITP) at New York University (NYU). Our program will catalyze interdisciplinary education at the
interface of chemistry and biology with a focus on two biomedical themes: Chemical Cancer Biology and
Chemical Microbiology. This training program will have participation from four basic science departments at
NYU: Department of Biology, Department of Chemistry, Center for Neural Science, and NYU Pain Center. All
programs are under the umbrella of NYU Graduate School of Arts & Science, enabling low barriers to joint
students and shared facilities. Participating faculty mentors have research interests in infectious disease,
neuroscience, and cancer chemical biology, with specific expertise spanning developmental biology, genomics
and proteomics, cell-signaling, organic chemistry, bioinorganic chemistry, enzymology, computation,
bioinformatics, neuroscience, and structural biology. Trainees are educated in the principles and techniques of
both chemistry and biology and take an interdisciplinary set of core courses to facilitate this knowledge. The
unique aspects of this program are that the program stresses joint mentors from different scientific disciplines
to encourage trainees to become proficient in chemical approaches applied to biological complexity as well as
approaches to science from different perspectives. The course work emphasizes rigor and reproducibility in
scientific research and scientific communication. All students will convert their key experimental methods into a
scientific video similar to those in the Journal of Visualized Experiments (JOVE) to be presented at the monthly
seminars or annual retreat. All trainees and mentors participate in the monthly Seminars in Chemical Biology
series as part of the NYU Chemical Biology Consortium, and the annual symposium and poster session.
Trainees will participate in their home graduate program research colloquia and student clubs in order to
broaden their knowledge and networking opportunities beyond the training program. In Years 4 or 5 of
graduate school, trainees will have an opportunity to pursue an internship at a pharmaceutical company or
entrepreneurial office to gain perspectives on careers outside academia. The number of mentors participating
in the CBI Training Program is 24 and four funded positions are requested in each year.

Public health relevance
Project Narrative Training graduate students for careers following attainment of the Ph.D. is one of the central missions of academic institutions. This grant is centered on training and education of Ph.D. scientists for careers that require knowledge at the interface of chemistry and biology. Since so much of biomedical research requires interdisciplinary knowledge, we view training at this junction to comprise a fundamentally important area for several different fields including academic research, the pharmaceutical industry, and non-traditional careers in science.